Intervention Optimization Core

Use continuation pages as neededto provide the required information in the format shown below. Start with Program Directpr(s)/Principal Investigator(s). List all other senior/key personnel in alphabetical order, last name first. Name eRA Commons User Name Organization Role on